Deciphering the role of Lmod2 in cardiac muscle and in dilated cardiomyopathy

PROJECT SUMMARY
Effective contractile force generation in muscle requires the proper assembly, regulation, and
activation of actin-containing thin filaments. The long-term goal of our work is to decipher the
mechanisms fundamental to the regulation of thin filament assembly and activation, and how
perturbations in these processes lead to myopathies. Leiomodins (Lmods) are a family of actin-
binding proteins that are critical for proper muscle function as mutations in all isoforms lead to
development of muscle disease. Loss of function variants in LMOD2, which is the cardiac muscle-
predominant isoform, cause severe infantile dilated cardiomyopathy (DCM). We previously
discovered that Lmod2 functions to elongate thin filaments, and is essential for normal cardiac
muscle function. In this current funding cycle, we found that Lmod2 impacts contractile activity
independent of its role in thin filament length regulation. We also found that multiple pathogenic
mutations result in loss of mutant LMOD2 protein expression due to nonsense-mediated mRNA
decay, which can be restored using LMOD2-specific steric-blocking oligonucleotides. Finally, we
have data revealing that serum response factor (SRF)-associated signalling is altered due to loss
of, or mutations in Lmod2. We hypothesize that Lmod2 is a multifunctional protein that influences
cardiac contractility through maintaining proper thin filament lengths and positively effecting
activation of the thin filament. We propose a multidisciplinary approach utilizing a unique
combination of in vitro assays, patient-specific induced pluripotent stem cell-derived
cardiomyocytes (iPSC-CMs), and novel mouse models of human disease - together with several
state-of-the-art approaches to accomplish three Specific Aims focused on determining: 1) the
mechanisms underlying the thin filament length regulatory function(s) of Lmod2; 2) how Lmod2
influences contractility, independent of its role in regulating thin filament length and 3) how loss
of, or mutations in, Lmod2 lead to DCM. Our integrative and comprehensive proposal will provide
critical missing links in our understanding of pointed end actin dynamics and muscle function. We
expect to identify signaling pathways that mediate Lmod2-linked disease progression and
determine if they represent potential therapeutic targets. These studies will have a broad impact
on understanding the etiology of a spectrum of diseases that result from mutations in thin filament
pointed end proteins and shed light on the pathogenesis of DCM, regardless of its initial cause,
as well as lay the groundwork for developing approaches to moderate disease progression.

Public health relevance
NARRATIVE Efficient generation of contractile force in muscle requires the proper assembly, maintenance and activation of actin-containing thin filaments. Here we propose to take a multidisciplinary approach to decipher how leiomodin 2 (LMOD2), a cardiac-specific actin-binding protein, regulates assembly and activation of the thin filament and how mutations in LMOD2 lead to dilated cardiomyopathy in humans. We aim to fill in gaps in our basic understanding of actin polymerization, contractile regulation, and pathological signaling pathways in the heart in order to lay the groundwork for potential therapeutic intervention for dilated cardiomyopathy.